Targeting T follicular helper cells for rejuvenating the aging germinal center

PROJECT SUMMARY
As humans age, their immune systems become dysfunctional. Specifically, aging impacts adaptive immunity
leading to a decline in vaccine induced secretion of high-affinity antibodies. We know a lot about cellular
responses to vaccines in aged individuals from investigating their blood. However, antibody responses evolve in
germinal centers (GCs) of secondary lymphoid organs, where T follicular helper cells (Tfh) facilitate the selection
of plasma cells that produce high-affinity antibodies. Limited access to human tissues has prevented us from
fully understanding how aging and age-associated frailty influences Tfh function in tissue and how they contribute
to a concomitant decline in antibody responses. The overarching hypothesis of this proposal is that age-
related changes in Tfh frequencies, positioning, and function in human lymphoid tissues contributes to
reduced vaccine efficacy in older adults. To address this, I have developed a research plan, spanning both
my training during the mentored K99 and independent R00 phase. Using a systems immunology approach,
integrating orthogonal transcriptomic, epigenomic, and phenotypic readouts, I will quantify age-associated
changes in Tfh heterogeneity in secondary lymphoid organs. I hypothesize that Tfh in secondary lymphoid
organs accumulate epigenetic changes with age, resulting in a transcriptional state of reduced metabolic
plasticity and muted cytokine responses, which is reminiscent of immune senescence. Next, using a novel in
vitro human tonsil organoid model and with the help of training proposed in this application, I will identify features
of Tfh that correlate with declining quality of antibodies following influenza vaccination in older adults. I
hypothesize that vaccination in older adults will result in poor Tfh differentiation, limited clonal expansion,
diminished phenotypic plasticity in GCs and consequently poor B cell help. Furthermore, I anticipate that Tfh-
focused immune modulation will improve quality of the antibody response in older adults. To test this
mechanistically, in the R00 phase, I will determine how Tfh frequencies and function contribute to poorly cross-
reactive antibody responses in older adults. Finally, I will test strategies to rejuvenate the aging GC, by using
immune modulatory agents targeting Tfh to overcome suboptimal influenza vaccine responses in older adults.
Gaining insight into the factors influencing diminished Tfh responses as individuals age will lay the groundwork
for enhancing vaccine effectiveness in older populations. The diverse scope of research outlined in this proposal
and an assembled team of mentors, co-mentors, and collaborators will provide me with training in aging biology,
microscopy, and antibody assays, which will complement my existing background in systems immunology.
Collectively, this training will facilitate my progression towards establishing an independent research program at
the nexus of immunology and aging.

Public health relevance
PROJECT NARRATIVE The population of the world is aging. Age impacts the body’s response to vaccines by reducing the quality and quantity of antibodies which are the main way vaccines provide protection from infectious disease. This proposal will study how aging affects T follicular helper cells, the cells that support B cells in producing high quality neutralizing antibodies, and test strategies to rejuvenate declining vaccine responses in older adults.